Hepatic FOXA3 Links NAFLD to Atherosclerosis

Project Summary
Project Summary: Non-alcoholic fatty liver disease (NAFLD) is one of the most common chronic liver diseases
worldwide, which includes simple steatosis (NAFL) and non-alcoholic steatohepatitis (NASH). NAFLD not only
causes liver dysfunctions but also induces extra-hepatic complications. Accumulating data indicate that
cardiovascular disease (CVD) is the major cause of deaths in NAFLD patients. So far, the mechanism underlying
the development of NAFLD is poorly understood. In addition, it is unclear why NAFLD patients have increased
incidence of CAD. Forkhead box A3 (FOXA3) is a transcription factor whose function in lipid or lipoprotein
metabolism has not been established. Our preliminary studies show that hepatic FOXA3 expression is markedly
reduced under common metabolic stress. Using over-expression or knockdown approaches, we show that
hepatic FOXA3 regulates hepatic lipid and plasma HDL levels as well as the expression of HDL-associated
proteins. These novel data suggest that dysregulation of hepatic FOXA3 may play an important role in the
pathogenesis of both NAFLD and CVD. To test this hypothesis, we will use both gain- and loss-of-function
approaches. Completion of the proposed studies may uncover a novel role of hepatic FOXA3 in the development
of NAFLD and atherosclerosis and may offer novel insights into the mechanism by which NAFLD is a risk factor
for CAD.

Public health relevance
Project Narrative Relevance: NAFLD is the most common chronic liver disease in developed countries and cardiovascular disease is the major cause of deaths in NAFLD patients. Completion of the proposed studies will help determine the role of hepatic FOXA3 in the development of both NAFLD and atherosclerosis, and may lead to a new strategy for treatment of these two common and causatively related diseases. Thus, this project is highly relevant to human health.